International Symposia on Recent Advances in Otitis Media

PROJECT SUMMARY
Partial support is being requested for three International Symposia on Recent Advances in Otitis Media. The
worldwide prevalence of otitis media (OM) and alarming increase in antibiotic resistant bacteria that cause OM
make this a serious public health problem. Thus, there is a pressing need for better ways to diagnose, treat
and ultimately, prevent OM. To do so however requires a complete understanding of all aspects of this
pediatric disease, a stated goal of both Healthy People 2020 (Hearing and Other Sensory or Communication
Disorders, ENT-VSL-2: “Reduce otitis media in children and adolescents”), and the NIDCD strategic plan FY
2017-2021, wherein Priority Area 2 – Understanding Diseases and Disorders, declares a mandate to improve
our understanding of the susceptibility and pathogenesis of OM as related to genetics, prior upper respiratory
tract infection, Eustachian tube dysfunction and reflux, bacterial biofilms and microbiome, polymicrobial
infections, dysregulation of innate immunity, inflammation and mucus production, mucosal hyperplasia and
dysregulation of the resolution of inflammation and tissue repair. Defining the immune pathways for effective
middle ear protection by vaccines and identification of new therapeutic targets as well as development of
animal models of acute and chronic OM, determination of the impact of vaccination on disease prevalence and
infection by other microbes are also cited as major goals within this priority research area. The objectives of
the International Symposia on Recent Advances in Otitis Media are fully and uniquely aligned with these
strategic goals. We strongly believe that the speed of scientific discovery requires regular broad and in-depth
review of the research progress in OM every two years. Importantly, an additional opportunity to define and
formulate recommendations for future research directions and funding every four years by the convening of an
integrated Research Conference within the Symposium (occurs during U.S.-convened symposia) is also of
great value to our collective efforts to identify and promote new and innovative research opportunities.
Thereby, with permission and recommendation from NIDCD staff, herein we request support that will span a
period of 5 years, during which we will convene the 20th , 21st and 22nd International Symposia on Recent
Advances in Otitis Media (in 2019, 2021 and 2023, respectively). The 20th Symposium will be convened June
9-13 in Los Angeles, California; the 21st Symposium will be convened June 6-10 in Tel Aviv, Israel; and the
22nd Symposium will be convened at a U.S. destination that will be decided at the 20th Symposium. These
Symposia are expected to foster improved communication amongst diverse research disciplines in the OM
research field and help close gaps in our collective knowledge and understanding of the pathogenesis as well
as the diagnosis, treatment and/or potential for immunological resolution of OM. This Symposium has also
consistently attracted young investigators from many disciplines and from around the world, thus ensuring a
future generation of both basic science and clinician investigators who will continue to move the field forward.

Public health relevance
PROJECT NARRATIVE Otitis media (OM) continues to present a tremendous global socioeconomic health care burden with a significant negative impact on quality of life, however recent advances in each of the many disciplines that comprise the field of OM research are fostering a greatly improved understanding of this complex of disease entities known collectively by the more generic term “OM’‘. This improved understanding and continued progress is essential to our overarching and collective goal to ultimately eliminate this highly prevalent pediatric disease and its sequelae, however much work remains to be done and as such, it is essential that we continue to come together at regular intervals to share advances and foster collaborate across disciplines to continue to make progress in the fast-moving world of scientific discovery. Support of the International Symposium on Recent Advances in Otitis Media (with its integrated Research Conference) will greatly facilitate our worldwide efforts in this regard.